Development of a low molecular weight synthetic Vi conjugate vaccine for salmonella typhi

Project summary
Salmonella typhi (S. typhi) is the major cause of typhoid fever which causes 9.2 million cases of the
disease and 110 thousand deaths as reported in 2019. Vaccines against S. typhi have been developed,
including Vi polysaccharide vaccine and more recently, Vi conjugate vaccines. They are based on the Vi
polysaccharide of S. typhi which is a linear alpha 1–4 linked polygalacturonic acid (PGA) that is N-acetylated at
C2 and O-acetylated at C3 of the galacturonic acid (Gal UA) residue. The O-acetyl group at C3 is the dominant
determinant of immunogenicity and potency. The Vi conjugate vaccines, overcoming the T-independence of Vi
polysaccharide vaccine, are T-dependent and effective in protection against typhoid fever in people > 6
months. However, because of the high molecular weight of Vi polysaccharide, these conjugate vaccines could
potentially still induce a partial T-independent response and hyporesponsiveness after booster immunization in
people under 2 years. Thus, conjugate vaccines with fragmented or low molecular weight Vi (~50 kDa) are
being developed as the potential fully T-dependent and more effective vaccines.
Production of Vi vaccines are complex and challenging due to reliance on bacterial fermentation and
processing difficulties and low yield of the Vi polysaccharide. Thus, synthetic Vi polysaccharides have been
generated and evaluated through an extensive series of studies initiated by scientists of NICHD (National
Institute of Child Health and Human Development). It is produced by O-acetylation of plant polygalacturonic
acid (PGA) which shares the same backbone as the Vi polysaccharide and are readily and abundantly
available. The resulting O-acetylated PGA (AcPGA) thus carries the dominant O-acetyl group epitope of Vi
polysaccharide. A phase I clinical trial with a synthetic Vi conjugate vaccine has been successfully conducted
by the NICHD team which showed that it is safe and immunogenic, thus providing a critical clinical proof-of-
concept for the synthetic Vi conjugate vaccine. Such a synthetic vaccine could provide significant advantages
over current Vi conjugate vaccine by eliminating the complex and challenging bacteria-based production
system. However, development of the synthetic Vi vaccines does face a significant challenge of potential
variation of plant PGA raw materials, especially in molecular weight, which in turn could lead to variation in
AcPGA or the synthetic Vi antigen. To overcome this challenge and also produce a more effective T-
dependent synthetic Vi polysaccharide, we have developed a simple and efficient process to generate low
molecular weight (LMW) AcPGA through controlled hydrolysis of AcPGA. The resulting LMW AcPGA has a low
molecular weight of 30-60 kDa and a high degree of O-acetylation (DOAc) which exceeds its specification for
Vi polysaccharide. We have further generated a LMW AcPGA conjugate with a novel nanoparticle carrier
protein (Dps, DNA-binding protein from starved cells) of Salmonella bacteria and showed that it is capable of
generating high titers of anti-Vi polysaccharide antibodies in rabbits, thus demonstrating the feasibility of this
LMW synthetic Vi conjugate vaccine. Based on these promising results, we propose to continue development
of this LMW synthetic Vi conjugate vaccine through two specific aims. Specific aim 1 will focus on generation
and characterization of LMW AcPGA while Specific aim 2 will focus on generation, characterization, and
immunogenicity evaluation of LMW AcPGA-Dps conjugates. The primary goals are to establish the optimal
processes and assays for production and characterization of LWM AcPGA and demonstrate the fully T-
dependent induction of anti-Vi polysaccharide antibodies by the LWM AcPGA-Dps conjugates.
Successful completion of the proposed studies will demonstrate production of the synthetic Vi antigen
(LMW AcPGA) from plant PGA raw materials and establish the LMW synthetic Vi conjugate vaccine candidate
(LMW AcPGA-Dps). They will form the basis for further development toward cGMP manufacturing
development and clinical studies. Successful development of this LMW synthetic Vi conjugate vaccine could
potentially provide a drastically improved Vi conjugate vaccine which will not only be produced more efficiently
with a higher capacity but could also be more effective by being fully T-dependent with its LMW synthetic Vi
polysaccharide.

Public health relevance
Project narrative Salmonella typhi is the major cause of typhoid fever and a significant global health concern. Current conjugate vaccines for controlling this bacterial pathogen are based on the Vi polysaccharide produced through a bacteria-based production system with poor yield. This project seeks to develop a low-molecular weight synthetic Vi conjugate vaccine based on modification of a structurally similar abundantly available plant polysaccharide. This synthetic Vi conjugate will not only be more readily available through its simple and efficient production process but could also be more effective in protection against this bacterial pathogen.